Motor Learning in Individuals with and at risk of Lower Limb Loss: Implications for Amputee Rehabilitation

Project Summary/Abstract
More than 1.6 million persons in the United States are living with the loss of at least one limb.[1] This number is
projected to more than double by the year of 2050 due to the aging population. While recent developments in
technology have led to sophisticated prostheses, the science underlying learning of prosthetic skills and
recovery of mobility after limb loss is not well understood, resulting in large variations in amputee patient
care.[2] Specifically, the principles and evidence of motor learning are not available to guide the process of
prosthetic skill training in this population.[3, 4] Recovery of mobility after lower limb loss remains a major
challenge especially for amputees who are older and with sensorimotor impairments from chronic diabetes.[5-7]
In the last 20 years, mounting evidence demonstrated that direction of attentional focus during execution of
motor tasks affects effectiveness of motor learning.[8] Specifically, directing one’s attention externally to the
movement outcome has been consistently shown to promote learning, when compared to an internal focus on
the body movements.[8-10] Manipulation of attentional focus has obvious implications in the clinical context of
learning prosthetic skills. If prosthetic motor skill learning can be improved through practice with an external
focus of attention, there would be a dramatic transformation in how patients with limb loss are rehabilitated.
This K01 Career Development Award will serve to develop my abilities as an independent researcher in the
field of motor learning as pertaining to amputee rehabilitation. My goals for this plan are to: 1) advance my
knowledge in motor learning science, and 2) obtain training in conducting clinical research in populations with
and at risk of limb loss. This plan is a logical extension of my background in clinical biomechanics and my
passion for translational research pertaining to amputee rehabilitation. The research projects I propose here
will advance our understanding of fundamental principles of motor skill acquisition in individuals with and at risk
of limb loss. This will lead to future development of evidence-based amputee rehabilitation strategies.
My home institution, the University of Nevada, Las Vegas (UNLV), is committed to advancing collaborative
research and educational activities in the health sciences. UNLV Department of Physical Therapy is currently
the meeting site for the Southern Nevada group of Amputee Coalition, with which I have active involvement.
Key UNLV faculty members who will serve on my Mentoring Committee include Robert Gregor (Professor
Emeritus, Georgia Institute of Technology; Research Consultant, UNLV School of Allied Health Sciences) and
Gabriele Wulf (Professor, UNLV Department of Kinesiology and Nutrition Sciences). Mentors external to UNLV
include Carolee Winstein (Professor, University of Southern California) and Robert Gailey (Professor,
University of Miami). Furthermore, the Medical Director of the Amputee Care Clinic in the Department of
Rehabilitation at the VA Southern Nevada Healthcare System, Dr. Eric Aguila, has agreed to assist this career
development and research plan by providing access to his patient population for the proposed research studies.
3

Public health relevance
Project Narrative Inadequate prosthetic training can result in poor patient outcomes, injuries, and wasted healthcare resources. This is a serious public health problem due to an aging population and rising prevalence of diabetes (main cause of amputation in the U.S.). With the proposed research, I aim to expand our understanding of motor learning in individuals with and at risk of lower limb loss to provide translational knowledge that will lead to more effective and efficient amputee rehabilitation strategies.